Full-scale GMP Production for a Pre-Clinical Systemic Delivered Mesenchymal Stem Cells Derived Extracellular Vesicles For Cardiovascular Disease

Project Summary/Abstract
Current therapies for patients with heart failure (HF) have limited efficacy because drugs and surgery can only
relieve the symptoms of HF but cannot save necrotic cardiomyocytes. Hence, there is an ongoing need to find
novel treatment strategies for HF following Myocardial Infraction (MI). Mesenchymal stem cells (MSCs) have
shown to improve cardiac function and reverse remodeling after MI where the underlying mechanism is
multifactorial and recently studies suggested that much of this repair can be attributed to extracellular vesicles
(EVs) that are released by MSCs. Main challenges impeding the translation of EVs into clinical application are
establishing advanced characterization method to document reproducibility and large-scale production for
clinical grade EVs. We have developed large-scale manufacture process using Quantum Bioreactors and this
project will aid in establishing methods to evaluate batch-to-batch variability. Our centralized hypothesis for this
project is that EV restore cardiac function by reducing cardiac remodeling through promotion of tissue
homeostasis, inhibition of inflammation, and promotion of angiogenesis. We hypothesize that repeated, systemic
delivery of WJMSC EVs will have additive impact for improving cardiac function and reducing cardiac remodeling
as compared to single dosing and WJMSC EVs provide underlying molecular mechanisms that is beneficial for
cardiac repair. Our study objectives are: 1) to evaluate the feasibility and safety of repeated injections of WJMSC
EV administered systemically in small animal model; 2) to observe effect on cardiac structure and function in an
experimental MI model; 3) to determine an optimal dose response. The long-term goal is to elucidate the
molecular mechanisms of WJMSC EV cargo on cardiac function and remodeling and the optimal dose and
regimen showing an improvement in cardiac function and reduced remodeling that will be used to investigate
the clinical effectiveness of our established clinical dose of WJMSC EV product in a large animal (porcine) MI
model. We are expecting that at least high dose of EV with repeated systemic administration will show greatest
improvement in cardiac function and seeing similar outcome with the medium and lower dose of EV. This would
coincide with absorption of EV into the heart tissue observed at 24 hours after administration and accompany of
finding key molecular mechanism of improving cardiac repair from RNA bioinformatic analysis. In addition, we
will be able to establish characterization criteria to reduce donor-to-donor variability. The positive outcome of this
study will establish the premise for moving toward large animal MI model and translating the technology and
innovation for clinical application.

Public health relevance
Project Narrative This study proposed to evaluate the effectiveness of repeated, systemic delivery of extracellular vesicles (EVs) in three doses secreted by Wharton’ Jelly derived mesenchymal stem cells (WJMSCs) in a murine myocardial infraction (MI) model. The optimal dose and regimen will be determined by evaluating the improvement in cardiac function and reduction in remodeling and proceed to the translation toward clinical effectiveness by evaluating in large animal (porcine) MI model. The study will also evaluate the molecular mechanism of EVs for cardiac repair and establishing characterization criteria to reduce donor-to-donor variability.